SCIENTIFIC ADMINISTRATIVE CORE (SAC)

ABSTRACT – Scientific Administrative Core (SAC)
Despite advancements in HIV prevention, treatment, and care in the context of modern antiretroviral
therapy (ART), reproductive age women are uniquely affected by HIV yet remain under-represented in HIV
research. During its inaugural funding, the Study of Treatment And Reproductive outcomes (STAR) sought
to address this gap by establishing a large, comprehensive, diverse cohort of reproductive age women with
HIV and demographically similar women without HIV across six Southern US sites representative of the HIV
epidemic in this high burden region, with longitudinal data collection on sociodemographic, psychosocial, and
clinical measures (including during pregnancy and for infants) along with laboratory tests and biospecimen
repositing. Building on its successful track record during its inaugural funding of efficient and collaborative
leadership, establishing the cohort, promoting science, and fostering mentorship, the STAR Scientific and
Administrative Core (SAC) is uniquely positioned to provide overall management, coordination, and
supervision of this proposed U19 program project award to continue STAR. Led by MPIs Drs. Maria Alcaide
and Anandi Sheth, the SAC will be the hub for all STAR activities proposed in this program project application
and will collaboratively develop, implement, and monitor STAR recruitment, retention, data collection along
with its scientific agenda and support for ESIs. The SAC will also provide administrative, regulatory, and fiscal
coordination of STAR initiatives, its Cores, and its Research Projects, by first (Aim 1), continuing and
expanding the STAR cohort by enrolling reproductive age women (ages 18-45 years) with HIV and
demographically similar women without HIV across six Southern US sites to longitudinally collect data and
biospecimens from a total of 1,400 participants (pregnant and non-pregnant women and their infants); second
(Aim 2), providing effective and efficient scientific, programmatic, regulatory and fiscal leadership through a
governance structure that supports the operational (via the Executive Committee) and scientific (via the
Scientific Leadership Group) goals of the program project; and third (Aim 3) catalyze scientific collaborations
by engaging established and early stage scientists through the SLG and Emerging Research Pilot (ERP)
program, advised by STAR’s advisory boards and groups. Building on the prior progress of the cohort and its
established leadership structure, coupled with robust institutional support and resources across all STAR-
affiliated institutions, the SAC will be ideally positioned to serve as the administrative and leadership hub to
continue and expand the cohort through its sites, provide effective regulatory and fiscal oversight, and develop
programmatic support for early stage investigators and other scientists, to ultimately advance science and
address health inequities across the reproductive life course.